HSP 70 GENE EXPRESSION IN SCID MOUSE BRAIN

DESCRIPTION: (adapted from applicant's abstract) The principal investigator wants to investigate the question whether the SCID mutation affects the expression of heat shock proteins (hsp70, hsc70, grp78) mRNA in the cerebellum and cortex following heat-induced transient hyperthermia. Her rationale for using SCID mice is that SCID mice are immunodeficient and cannot produce differentiated B- or T-cell nor process Class II histomolecules. Hsp70 is located in the HLA class region and it is unknown whether the SCID mutation (a mutation in the DNA-dependent protein kinase subunit located on mouse chromosome 16) will alter the Hsp70 expression.